Career Enhancement Program

CAREER ENHANCEMENT PROGRAM (CEP): ABSTRACT
The Career Enhancement Program provides a highly structured mechanism to select and mentor junior investigators interested in careers in prostate cancer research. The Career Enhancement Program (CEP) uses several mechanisms to recruit these investigators including emails, letters to department chairs and web site announcements. In addition, the Directors of the Robert H. Lurie Comprehensive Cancer Center and the University of Chicago Comprehensive Cancer Center advertise the CEP when recruiting junior investigators to their respective Institutions. CEP investigators are selected after careful review of their credentials, their proposed projects and their potential to develop an independent career in prostate cancer research. Career Enhancement investigators are clinicians or basic scientists from biomedical science departments at Northwestern University, University of Chicago and NorthShore University HealthSystem. The fact that the awardees come from a variety of departments provides a source of broad scientific expertise to members of the SPORE Program.
The Career Enhancement Program has flexibility in terms of offering awards and the length of the award. However, there is a consistent and highly-structured process for solicitation and selection of CEP investigators and a good tracking system for monitoring their progress.

Public health relevance
CAREER ENHANCEMENT PROGRAM (CEP): PROJECT NARRATIVE The Career Enhancement Program is a critical component of the SPORE in Prostate Cancer, in that it ensures that there will be a continuous influx of talented investigators devoted to prostate cancer research.